Understanding renal intrinsic repair by FANCD2

Project Summary
Chronic kidney disease (CKD) affects up to 13.4% of the global population, imposing significant economic
burdens on healthcare systems. While kidney tubular cells can self-repair, severe or repetitive damage may
lead to degenerative fibrosis, revealing critical gaps in understanding adaptive cellular repair mechanisms. Our
recent work has identified unique molecular profiles in repairing tubules, indicating that FANCD2, a key protein
in the Fanconi anemia pathway and crucial for interstrand crosslink (ICL) repair, may regulate adaptive repair.
Despite extensive studies on FANCD2 in DNA repair and cancer, its role in the kidneys and CKD is
poorly understood. No studies have reported the kidney phenotype of FANCD2 knockout (KO) mice; however,
data from the International Mouse Phenotypic Consortium (IMPC) suggest kidney degenerative changes in
heterozygous KO males. Furthermore, clinical studies indicate an association between Fanconi anemia and
CKD, emphasizing the relevance of this research. Our investigation revealed a unique pan-nuclear distribution
of FANCD2 in proximal tubules, distinct from typical DNA repair foci. Additionally, chromatin
immunoprecipitation sequencing (ChIP-seq) analysis showed FANCD2 binding to the promoters of multiple
genes, including those involved in kidney development. In cisplatin-induced acute kidney injury (AKI) mouse
models, we observed protective effects of inhibiting FANCD2's canonical pathway. These findings suggest
FANCD2 has multifaceted roles beyond its ICL repair, significantly impacting kidney development and repair
through non-canonical pathways.
Specific Aim 1 is to define the non-canonical role of FANCD2 as a transcriptional regulator in nephron
epithelia. We will use diverse models, including conditional FANCD2 KO mice, transgenic human kidney
organoids, and patient samples, employing techniques such as immunohistochemistry, 3D imaging, western
blotting, qPCR, RNA-seq, and ChIP-seq. These integrative analyses will assess FANCD2 chromatin binding
and transcriptional regulation. Specific Aim 2 is to investigate FANCD2’s roles in AKI and CKD through both
canonical and non-canonical pathways using in vivo and in vitro models. We will employ genetic and
pharmacological approaches to uncover these roles. Our evaluation will include nephron epithelial integrity,
fibrosis, DNA damage and repair, and other processes through single cell analyses, providing insights into
FANCD2’s pathways as a potential therapeutic target.
These aims utilize diverse models to rigorously test our hypothesis and provide evidence for potential
CKD interventions. Our comprehensive approach aims to enhance understanding of FANCD2-mediated kidney
repair mechanisms. Unraveling the non-canonical roles of FANCD2 in CKD may lead to targeted therapies that
halt fibrotic progression and improve renal function in CKD patients.

Public health relevance
Narrative The proposed research aims to uncover the mechanisms underlying renal intrinsic repair through the utilization of transgenic mouse and human organoid models. Our investigation will focus on delineating the role of FANCD2 in tubular repair and its influence on the development of fibrosis, with a particular emphasis on exploring the transcriptional regulation governed by FANCD2. The integration of transgenic models in both human organoids and mice will be instrumental in maintaining a rigorous scientific approach throughout our studies.